Understanding and addressing the lack of and delayed screening for primary Aldosteronism

PROJECT SUMMARY/ABSTRACT
Primary aldosteronism (PA) is the most common cause of secondary hypertension, accounting for up to 15% of
cases. Compared to primary hypertension, PA is linked to a 12-fold increased risk of adverse cardiovascular and
renal events and increased mortality. Despite guideline recommendations for screening and the availability of
screening tests and effective treatments, only 2% of at-risk individuals undergo PA screening. Further, the small
proportion of individuals who are evaluated for PA often undergo screening too late, after they have already
developed preventable cardiovascular and renal complications. However, the factors driving low and delayed
PA screening rates, as well as potential racial and ethnic disparities in screening, have not been thoroughly
investigated, despite known disparities in hypertension outcomes in these groups. This project will identify
patient, clinician, health care system, and societal factors contributing to inadequate and delayed screening
following the Health Equity Implementation Framework to inform the development of future interventions that can
improve the frequency, timeliness, and equity of PA screening. The long-term objective of this project is to ensure
timely, evidence-based, and equitable care for all individuals at risk of PA. In Aim 1, we will establish current
patterns of PA screening and racial-ethnic disparities by leveraging linked datasets, encompassing insurance
claims and electronic health records of enrollees in private and Medicare Advantage health plans within the
OptumLabs Data Warehouse (OLDW), connected to a 100% sample of Medicare fee-for-service beneficiaries
(M-FFS). Significantly, the OLDW-M-FFS data originates from primary care practices (~70%), and non-academic
institutions (~80%), mirroring real-world practices. Innovative machine learning techniques will be employed to
model and identify factors associated with the frequency of PA screening and the duration of hypertension before
testing. In Aim 2, we'll use a mixed-methods approach to explore factors behind the underutilization of evidence-
based PA screening. Surveys and interviews with patients, clinicians, and practice leaders will be conducted
across three large healthcare systems (University of Florida, Mayo Clinic, University of Michigan) and 10 regional
sites, with significant representation of primary care and rural practices. Finally, Aim 3 will use a Delphi-based
implementation mapping approach to identify feasible and acceptable strategies targeting specific factors related
to PA screening through collaboration with representatives from patient groups, clinicians, and health systems.
By the end of the study, we'll have identified factors contributing to inadequate and delayed PA screening,
offering a comprehensive, multilevel understanding of barriers and facilitators. Moreover, we'll propose mitigation
strategies that are acceptable and feasible to important stakeholder groups from different settings. These
findings will lay the foundation for developing and testing interventions to support evidence-based PA screening,
improving health outcomes and reducing the burden of preventable morbidity and mortality associated with PA.

Public health relevance
PROJECT NARRATIVE The project will identify and address factors contributing to the lack of and delayed screening practices for primary aldosteronism (PA), a prevalent and treatable cause of high blood pressure and cardiovascular events. Through comprehensive analysis of patient, clinician, health care system, and societal factors, innovative machine learning techniques, mixed methods research, and stakeholder collaboration, this project will identify tailored strategies to improve the frequency and timeliness of evidence-based and equitable PA screening for at-risk individuals. In turn, enhanced screening practice will improve health outcomes, reduce preventable morbidity and mortality, and ensure equitable care for individuals at risk of PA.